URINARY CONTINENCE STATUS AND TREATMENT OF INCONTINENCE IN NURSING HOME RESIDENCE

Urinary incontinence is prevalent in nursing homes. This project was designed to test the effectiveness of staff performance feedback in conjunction with behavioral treatment of incontinence.